Amelioration of Cardiac Fibrosis Using Diverse Cell Village Human Cardiac Organoids

Project Summary
Cardiac fibrosis, the excessive buildup of fibrous connective tissue in the heart resulting in impaired
function and structure, is a prominent hallmark of dilated cardiomyopathy (DCM), and significantly contributes to
the pathogenesis of this inherited heart disease. DCM is characterized by systolic dysfunction and the
enlargement of ventricular chambers, often linked to mutations in myocyte-specific genes that impair contractile
function. However, beyond myocyte dysfunction, non-myocyte elements play a crucial role, particularly in the
form of cardiac fibrosis and endotheliopathy. Notably, the extent of fibrosis correlates with the progression of
DCM and serves as a critical predictor of adverse patient outcomes, including the development of heart failure.
This strong association suggests a possible causal relationship between cardiomyocyte (CM), and endothelial
cell (EC) dysfunction which results in the dysfunctional activation of fibroblasts (Fb) from a quiescent state turning
into ECM-secreting myofibroblasts. To discover a way to combat fibroblast activation, we will take two hits from
a screen of 5,000 FDA-approved compounds that was previously performed in the lab, with the goal of validating
them in a complex human 3D iPSC cardiac organoid (iPSC-CO) initially, followed by further validation in a mouse
model of LMNA DCM. iPSC-CO will be generated from 20 sex and racially diverse iPSC lines (10 healthy, 10
DCM) currently available to our lab, and pooled into 2 cell villages before differentiation into CM, EC, and Fb.
Using whole genome sequencing in tandem with single nucleus RNAseq and ATACseq, we will profile the
transcriptome and the chromatin state of each cell within the organoid, enabling us to assign a cell line identity
to the exact cell line origin. In addition, these organoids will be physiologically profiled using measurements of
fibrosis and stiffness through AFM contraction kinematics. These two hits will also be tested in an animal model
of DCM, the LMNAH222P mouse. The cardiac tissue of these mice naturally becomes excessively fibrotic by 20
weeks of age, so treatments will begin 1 month before, and will be monitored using echocardiography and tail
pressure cuff. At the end of the experiment these animals will be used for 10x multiomics analysis as well as
histological and immunological analysis of fibrosis. Here, our research aims to uncover effective strategies to
mitigate the detrimental effects of cardiac fibrosis in diseases like DCM. By validating and describing the anti-
fibrotic mechanism of two hits from prior compound screen, CGS15943 an adenosine receptor antagonist and
AM404 a TRPV1 agonist, and correlating their efficacy in the LMNA DCM mouse model, we aim to provide a
therapeutic for those affected by DCM. Using advanced techniques like whole genome sequencing, single
nucleus RNAseq and ATACseq, and pairing it with physiological profiling, our study will reveal the interplay
between three cardiac cell types, CM, EC, and Fb potentially leading to new treatments and knowledge to better
combat excessive cardiac fibrosis.

Public health relevance
Project Narrative Cardiac fibrosis occurs in many common diseases which results in decreased heart function over time, and often leads to heart failure. Unfortunately, there are currently no FDA-approved drugs that would help improve the life and health span of those individuals affected. Here, we outline a series of experiments with the goal of evaluating the effectiveness two potentially anti-fibrotic compounds previously identified by our lab in a high throughput cell culture model of cardiac fibrosis, and validating them in both rodent and genetically diverse 3D human iPSC cell models.